Oral Fluid Testing to Assess Cannabis Non-Use in Remote Clinical Trials

PROJECT SUMMARY/ABSTRACT
Younger adults aged 18-30 years are using cannabis frequently and experiencing the dysfunction and distress
of cannabis use disorder (CUD) at unprecedented rates. Facing numerous barriers to treatment and lack of
diverse representation in research, younger adults with CUD need expanded opportunities to access
interventions and to participate in clinical trials. Remote implementation offers a promising means to addressing
these critical gaps in care and research. However, valid remote procedures for biologic assessment of a key
outcome, reduction in cannabis use days, have not been established. We propose an approach to assessing
cannabis use and non-use remotely via oral fluid testing, which can be directly observed, is easily and quickly
accomplished with minimal training, has a short detection window (≤24-72 hours after cannabis use) and is less
prone to alteration or falsification vs. urine and other biologic specimens. Using our experience with studying
cannabis use in younger adults, telehealth preferences, fully remote interventions, and collecting and testing
biologic specimens, we propose to evaluate a community sample of 200 individuals aged 18-30 years with past-
30-day cannabis use ≥1x/week. Participants will videorecord of daily oral fluid delta-9-tetrahydrocannabinol
(delta-9-THC) testing on 6 consecutive days and live observed testing on the 7th day. We will assess completion
of daily oral fluid testing and its performance in identifying cannabis use/non-use intervals, vs. self-report on
timeline follow-back calendar interview. To do so, we will analyze performance of oral fluid test results over each
period of 3 consecutive days, corresponding to a cannabis use/non-use interval of 4 days, which, based on our
research, is a meaningful period of non-use following treatment in individuals who use cannabis frequently (5
possible 3-day testing intervals/participant, resulting in ≤1,000 intervals). We will also contrast oral fluid results
with urine results to demonstrate the relative utility of oral fluid testing for establishing use/non-use over short
intervals. The specific aims are 1) to establish the feasibility of remote testing for oral fluid delta-9-THC using
video recordings on a personal device and live observation via videoconference call. We will used a mixed
methods approach, including staff observation, participant survey, and participant interview to evaluate
implementation, completion, acceptability, burden, and technical aspects of the oral fluid testing procedures; 2A)
to determine agreement between oral fluid test results over 3 consecutive days (any positive = use, all negative
= non-use) and self-reported cannabis use/non-use over the corresponding days on TLFB (4 days, 3 plus 1 day
earlier); and 2B) to demonstrate agreement between results on a single oral fluid test and a single urine test
obtained contemporaneously in individuals who have used cannabis ≥1x/week in the past 30 days. Identifying
an approach to biologic assessment of cannabis non-use days that can be accomplished under video
observation will substantially add to the rigor of remote clinical trials for CUD. Younger adults will particularly
benefit from the enhanced evidence on remote interventions for CUD.

Public health relevance
PROJECT NARRATIVE/RELEVANCE Facing historically high and increasing rates of cannabis use disorder and numerous barriers to treatment, younger adults aged 18-30 years will benefit from expanding research on interventions that can be studied and delivered in the virtual environment. However, valid remote procedures for biologic assessment of reduction in cannabis use days, an important indicator of treatment efficacy, have not been established. This study will establish the feasibility of oral fluid testing for delta-9- tetrahydrocannabinol (delta-9-THC) to assess cannabis use/non-use days remotely and evaluate its agreement with conventionally used measures, self-reported cannabis use on timeline followback calendar interview and urine testing for carboxy-THC.